2023 Epigenetics Gordon Research Conference and Gordon Research Seminar

Project Summary
Heritable changes in phenotype not caused by changes to the DNA sequence are referred to as epigenetic.
Epigenetics governs multiple aspects of normal cellular function and growth and development. Epigenetic
effects are mediated by DNA modifications, non-coding RNAs, histone variants and modifications, higher order
chromosomal structures, infectious proteins, and possibly other molecules. The objectives of the 2023
Epigenetics Gordon Research Conference (GRC) are to present a scientific program that reflects the breadth
and depth of epigenetics research and to promote diverse and inclusive science and the careers of young
investigators. The preliminary program includes speakers studying aspects of epigenetics in mammals
(including humans), worms, flies, yeast, and flowering plants. Invited speakers range from early career
investigators to senior leaders in the fields. Other important aspects of the GRC program include ample time
for discussion and networking, poster preview talks for young investigators, poster prizes, and the GRC Power
Hour, which addresses challenges faced by younger scientists and by scientists from underrepresented
groups. The 2023 Epigenetics Gordon Research Seminar precedes the GRC and offers an opportunity for
students and postdoctoral scholars to present their work and develop peer relationships. The GRS will also
include mentoring sessions with senior scientists. Overall, the GRC and GRS programs will promote cross-
disciplinary, innovative, and inclusive science that will advance the field of epigenetics. The GRC and GRS
was cancelled in 2021 and thus the 2023 meetings are critical for maintaining vibrancy of the field.

Public health relevance
Project Narrative Epigenetic information is contained outside of the DNA sequence and its proper patterning is essential for normal growth and development. This conference will bring together a diverse group of researchers addressing the nature of epigenetic information and the molecular mechanisms by which it is remembered and inherited, including how these processes are altered in disease states, such as birth defects, cancer, and rapid aging.